Project 1

Despite more than a decade of implementing universal access to antiretroviral therapy (ART) in sub-Saharan
Africa (SSA), Kaposi’s sarcoma (KS) remains the most common malignancy in people living with HIV/AIDS
(PLWH), causing significant morbidity and mortality. Compared to the US, ART implementation in SSA has not
resulted in a significant reduction of KS cases. For many PLWH in SSA, the only connection to health care is
through HIV care and treatment centers (CTC). Lack of recognition of early KS by both CTC care providers
and PLWH, and ineffective connection to diagnosis, care, and treatment when the disease presents in the
setting of HIV management at CTC may foster late presentation and ultimately, poor outcomes. Compared to
cervical cancer, where screening and early detection approaches have been successfully integrated into HIV
care for PLWH, efforts to detect, diagnose, and treat KS early are lacking. Since KS presents mostly
cutaneous, coupling KS detection to HIV management as has been done in cervical cancer for early detection
should readily improve early KS detection, definitive diagnosis, and linkage to care. As services for HIV
management are conducted through CTCs throughout SSA, these community-associated structures are the
best platform to integrate KS interventions and can be leveraged to increase early-stage presentation, early KS
diagnosis, and early treatment initiation. In this study, we will implement an integrated education package to
raise awareness and to impart the skills for early KS detection and diagnosis to PLWH, health care providers,
and community workers. This package includes recurrent educational sessions at CTCs in order to enhance
detection, diagnosis, and to initiate KS treatment early to improve outcomes of PLWH. It will also include a
social network-based strategy to enhance the sustainability of such an implementation program. We
hypothesize that an integrated care approach will increase the number and proportion of PLWH detected with
early KS, thereby improving early KS diagnosis and treatment to improve KS outcomes. There are 3 Specific
Aims. 1) Implement KS education, early detection, diagnosis, and linkage to care program at CTCs in Tanzania
and Zambia. 2) To enhance and sustain early KS detection, diagnosis, and linkage to care program through a
community network-based respondent-driven sampling (RDS) strategy in Tanzania and Zambia. 3) To
evaluate the effectiveness of integrating early KS detection, diagnosis, and RDS strategy in existing HIV care
services for PLWH in Tanzania and Zambia. Together, this will determine whether sensitization of providers
and PLWH to a combined HIV care and early KS detection approach is efficacious and viable in the setting.
This study is significant, as it will increase the proportion of PLWH examined for early KS detection, diagnosed,
and linked to cancer care. It will also focus on empowering and equipping providers and PLWH to make more
informed health decisions. This can be readily adopted and scaled up in Tanzania and Zambia, and
subsequently in other SSA to facilitate early KS diagnosis and treatment.

Public health relevance
NARRATIVE The lack of recognition of early Kaposi's sarcoma (KS) by both the health providers and PLWH, ineffective connection to diagnosis and care are some of the factors that make KS the most common malignancy in people living with HIV/AIDS (PLWH), in sub-Saharan Africa (SSA), causing significant morbidity and mortality. This study will implement an integrated KS education, diagnosis and treatment package at the Care and Treatment Clinics in order to enhance detection, and to initiate KS treatment early to improve outcomes of PLWH. This study is significant as it will lead to early KS detection, diagnosis, and linkage to care that will improve treatment outcomes and it can be readily adopted and scaled up in Tanzania and Zambia, and subsequently in other SSA countries.